Use of the KF Modified Story Memory Technique to Improve New Learning and Memory in Individuals with Mild Cognitive Impairment

Project Summary
Prevalence rates for Mild Cognitive Impairment (MCI) range from 7-25% for adults over the age of 60, with
risk increasing with age. Impairments in new learning and memory (LM) are common in persons with MCI and
negatively impact several aspects of everyday life, including independence in daily activities and social
functioning. Despite the demand for LM treatments by older adults and clinicians alike, few cognitive
rehabilitation (CR) protocols to date are supported by Class I research evidence, thereby limiting the degree to
which potentially efficacious treatments can be applied to individuals with MCI.
The Kessler Foundation modified Story Memory Technique (KF-mSMTTM) is a manualized, 10-session CR
protocol designed to treat impaired LM. Over a decade of research and development conducted at our center
has demonstrated the KF-mSMT to be effective for improving LM in individuals with neurological conditions (e.g.,
MS, TBI), across three realms of functioning (objective behavior, neural functioning, and everyday life) with
improvements maintained over time. This convincing data provides Class I evidence supporting the efficacy of
the KF-mSMT for improving LM in these populations. In addition, we have accumulated strong pilot data on the
efficacy of the KF-mSMT in individuals with MCI, highlighting the likely successful application of the KF-mSMT
to individuals with MCI.
We will conduct a multi-site, double-blind, placebo-controlled randomized clinical trial (RCT), administering
the KF-mSMT to 120 participants who meet criteria for MCI. Outcome will be assessed immediately following
treatment, 6 months following treatment as well as 18 months following treatment to examine the long-term
impact. Outcome will be measured via 3 mechanisms: (1) Neuropsychological Evaluation (NPE) to examine
post-treatment changes on objective cognitive performance (2) Assessment of Global Functioning (AGF) to
examine post-treatment changes in cognition in daily life and (3) functional magnetic resonance imaging (fMRI)
to examine pre to post-treatment changes in patterns of cerebral activation underlying LM performance. The
examination of daily life activities as an a priori endpoint in this RCT is a highly innovative aspect of the proposed
work, highlighted as a significant gap in the rehabilitation literature by many experts in CR. Importantly, the
rigorous research design employed in the current study is highly responsive to the objectives set forth by the NIA
in their strategic directions (p.14), to “determine how individuals can maintain function with age or regain that
function after loss due to immobility, illness, or trauma”, while also designed to identify the “mechanism through
which common interventions, both medical and behavioral, may slow the physical and cognitive decline.”

Public health relevance
Project Narrative Impairment in new learning and memory is a hallmark symptom of Mild Cognitive Impairment (MCI) and negatively impacts several important aspects of everyday life (e.g., instrumental activities of daily living), but treatment options are limited due to the lack of cognitive rehabilitation (CR) protocols supported by Class I research evidence. To address this critical need, the presently proposed multi-site randomized clinical trial (RCT) examines the efficacy of the Kessler Foundation modified Story Memory Technique (KF-mSMT), a 10-session structured CR treatment composed of the application of imagery and context to facilitate learning. Results are expected to substantially improve our ability to treat learning and memory deficits in persons with MCI, which would lead to improved everyday functioning and overall quality of life for persons with MCI, as well as reduced caregiver burden and slowed transition to dementia.